Transmission Aerobiology of M. tuberculosis: Genes and Metabolic Pathways That Sustain Mtb Across an Evolutionary Bottleneck

ABSTRACT
Unless COVID overtakes it, tuberculosis is likely to keep its grip on its grim record of being the leading
infectious cause of human death. Humans are the only known natural host and transmitting reservoir for the
causative agent, Mycobacterium tuberculosis (Mtb). This means that person-to-person transmission through air
is essential for Mtb's survival as a species. Despite multifaceted efforts to reduce TB's transmissibility, TB's
reproductive number, Ro, remains among the highest of frequently-lethal infectious diseases. Aerogenic
transmission is a stage in Mtb's life cycle that must have been subjected to strong evolutionary pressures, yet
our knowledge of Mtb's transmission biology is sorely lacking. The problem has been nearly inaccessible to
basic-science study for want of suitable technologies and animal models. This Program Project proposes to lay
a basic-science foundation for potential new transmission blocking interventions by bringing a synergistic
combination of investigators and disciplines together for a collaborative attack that mobilizes genome-wide
screening under transmission-relevant conditions, characterizes Mtb's metabolomic, lipidomic and biochemical
responses to those conditions, introduces and improves animal models, and uses aerosol physics as a guide
and tool. Project 1 will identify genes that Mtb requires to survive the transitions between major states that the
pathogen encounters en route to, during and after aerosol transmission. Project 2 will identify conserved,
essential metabolic programs in Mtb that have evolved in response to transmission-related stresses, such as
changes in humidity and gas composition. Project 3 builds on the recent discovery of cough-inducing lipids
produced by Mtb to characterize an even more potent tussive lipid as a virulence factor and to develop a model
of cough-based transmission among guinea pigs. Project 4 characterizes the physical and rheological
properties of respiratory fluids relevant to TB transmission and uses that information to control the mechanical
generation of physiologically relevant, respirable aerosols of Mtb. Core A ensures the efficient flow of
information, personnel and materiel among these interconnected units, while Core B develops a mouse model
of simulated transmission using the aerosolization device and settings of Project 4 and applies that model to
confirm which genes Mtb depends on to survive aerosol transmission to a new host.

Public health relevance
NARRATIVE Tuberculosis remains a leading cause of death from infection because the causative agent, Mycobacterium tuberculosis (Mtb), is highly successful at moving in airborne micro-droplets from the damaged lungs of one coughing, talking or sneezing person to the healthy lungs of several others. To succeed in this journey, Mtb must survive drastic, rapid, sequential changes in the composition of the surrounding fluid; the concentrations of oxygen, carbon dioxide, water and hydrogen ions; and the ambient temperature. This Program Project brings new technologies and animal models to bear to characterize Mtb's transmission biology at genomic, metabolomic and lipidomic levels; to use the physics of respirable aerosols to guide the development and use of a mouse model for testing genetic hypotheses; and to improve on the historic guinea pig model of natural transmission through new molecular knowledge of how Mtb makes an infected host cough.